Risk stratification in pulmonary arterial hypertension: Intersection of OMICs and longitudinal phenotypes through the PAH Biobank

Pulmonary arterial hypertension (PAH) is a rare, fatal condition characterized by the gradual occlusion of the
pulmonary arterioles leading to progressively increased pulmonary vascular resistance with worsening right heart
failure and death. While rare mutations (e.g., in BMPR2) have been reported in a minority of patients, most
patients carry no established mutations. We recently published on common genetic variation in 2,085
idiopathic/heritable (I/H) PAH cases and 9,659 controls of European ancestry using a genome-wide association
(GWA) approach. Discovery and replication analyses were conducted in four independent cohorts with
genotyping arrays from our US-based PAH Biobank (PAHB) study and three international cohorts with whole
genome sequence data. We reported two novel loci, at HLA-DPA1/DPB1 and near SOX17 associated I/H PAH.
HLA-DPA/DPB1 locus predicts a reduced annual mortality rate by 25-37% in I/H PAH. The lead SOX17 variant
is located in a putative enhancer region in close spatial proximity to the SOX17 gene in endothelial cell (EC)
precursors, which influences its expression based on our experimental validation. Our findings provide the first
support for the contribution of common genetic variance to PAH risk and, combined with the recently reported
data on rare mutations in SOX17 in PAH, highlight the causal role of SOX17 in PAH. Beyond PAH risk, we now
hypothesize that PAH progression and outcomes are also genetically modified including from SOX17, a
transcription factor, and HLA-DPA1/DPB1 as both novel candidate genes and possible therapeutic targets. To
test this hypothesis, we have developed 3 specific aims (SAs) that will further expand the PAHB, the world’s
largest PAH biobank, registry, and multi-omics dataset with whole exome sequencing (WES), RNAseq, whole
genome genotyping, and non-targeted metabolomics data on nearly all subjects. SA #1 will collect serial
longitudinal data in PAHB to interrogate associations between disease risk loci (SOX17, HLA-DPA/B1) with
markers of PAH progression. We will also evaluate expression (eQTL) and metabolomics (mQTL) quantitative trait
loci analyses for functional validation. Beyond disease risk SOX17/HLA loci, we generated additional preliminary
data revealing genome-wide significance for seven novel genetic loci associated directly with survival in PAH in
a second, independent PAH cohort. SA #2 will now replicate these new findings with outcomes (progression and
survival) collected in PAHB from SA #1. As a unique feature of this proposal, we will interrogate our top loci in two
other global PAH cohorts with available eQTL and mQTL data and perform a meta-analysis of all cohorts. We will
also construct a risk stratification tool combining clinical risk factors and genetics (SOX17, HLA, 7 SNPs) for PAH
outcomes. Finally, based on preliminary data on the protective role of SOX17 in EC function, SA #3 will validate
the biological role of SOX17 pathway in the development of PAH using ECs/SMCs isolated from PAH patients
as well as pre-clinical testing in murine PH models. Strong clinical association of these two new loci has
implications for prediction of clinical outcomes, clinical trial design, and the development of novel drug targets.

Public health relevance
Pulmonary arterial hypertension (PAH) is a rare condition characterized by gradual occlusion of the small pulmonary arterioles leading to progressively increased pulmonary vascular resistance (PVR), right heart failure and death. Although causal mechanisms are unclear, our data, for the first time, show evidence of common genetic variation in two novel gene targets associated with the risk of developing PAH in the largest available PAH cohort studied to-date. Our studies will now shed insight into whether these two novel modifier genes contribute to the risk of disease progression and outcomes as well as provide new potential therapeutic targets in PAH.